Abramson Cancer Center Support Grant

PROJECT SUMMARY
This project seeks to develop, apply, and disseminate informatics tools for building a Childhood Cancer
Isoform Atlas, enabling multiomics-augmented and big data-informed studies of alternative isoform variation and
resulting immunotherapy targets using Childhood Cancer Data Initiative (CCDI) data. Alternative splicing (AS) is
a prevalent mechanism for generating transcriptomic and proteomic diversity. AS is frequently dysregulated in
cancer cells and contributes to the various “hallmarks of cancer”. Compelling evidence suggests that protein
isoforms resulting from dysregulated AS represent a vast yet understudied repertoire of tumor antigens and
potential targets for cancer immunotherapy. Thus, a systematic exploration of alternative isoform variation in
CCDI and other pediatric cancer data repositories will enhance our understanding of cancer pathophysiology
and accelerate clinical translation through the discovery of novel biomarkers and therapeutic targets.
The accumulation of large-scale RNA-seq, proteomic, and clinical data in pediatric cancer data repositories,
including data held in the CCDI Data Ecosystem, provides unprecedented opportunities to uncover the biological
significance and therapeutic potential of alternative isoform variation in pediatric cancer. Advances in long-read
RNA-seq strategies for transcriptome analysis and proteotranscriptomic data integration enable the
comprehensive determination of full-length transcript and protein isoforms as well as the resulting antigen
repertoire of pediatric cancer. However, to make full use of these cutting-edge technologies and rapidly growing
data resources, robust, scalable, and user-friendly informatics tools are needed.
Our multidisciplinary team has deep expertise in computational biology, transcriptomics, and multiomics data
integration (Xing), as well as clinical pediatric oncology, pediatric hematological malignancies, and cancer
epidemiology (Aplenc). We have developed and disseminated innovative algorithms and widely used software
for characterizing AS and isoform variation using short-read and long-read RNA-seq data (rMATS, ESPRESSO),
and for discovering AS-derived cancer immunotherapy targets (IRIS, IRIS-long). Building on our expertise, we
will apply and enhance our informatics tools to: 1) define the landscape of alternative isoform variation, 2)
discover immunotherapy targets, and 3) integrate and visualize data on alternative isoforms and immunotherapy
targets in pediatric cancer. The proposed research is directly responsive to the objectives of the RFA seeking
studies that involve the 1) aggregation, integration, analysis, and visualization of CCDI datasets, and 2)
development and deposition of new tools into the CCDI data ecosystem to enhance data re-use. All software
developed in this project will be made open source, readily usable on NCI-supported cloud computing systems,
and freely available to the research community. Overall, this project will generate broadly applicable tools and
novel resources to enhance the utility of CCDI data for elucidating alternative isoform variation and discovering
novel immunotherapy targets for hard-to-treat pediatric cancers.

Public health relevance
PROJECT NARRATIVE Pre-mRNA alternative splicing is a prevalent mechanism for generating transcriptomic and proteomic diversity in cancer cells. This project aims to develop, apply, and disseminate informatics tools for building a Childhood Cancer Isoform Atlas, by analyzing data in the Childhood Cancer Data Initiative (CCDI) Data Ecosystem as well as other pediatric cancer data repositories. The proposed work will generate broadly applicable tools and novel resources to enhance the utility of CCDI data for elucidating alternative isoform variation and discovering novel immunotherapy targets for hard-to-treat pediatric cancers.